ESTROGEN INDUCED PROTEINS IN VASCULAR SMOOTH MUSCLE

The investigators propose that estrogens induce expression of proteins in coronary smooth muscle which inhibit the smooth muscle proliferation associated with atherogenesis. Their study aims to identify these estrogen-induced proteins via molecular techniques, utilizing smooth muscle cells from men & postmenopausal women not on HRT after exposing the cells to estrogen. Based on the findings, levels of mRNA's will be measured in men and postmenopausal women not on HRT & compared to levels in postmenopausal women on HRT or premenopausal women.